Novel Computational Framework for Free-Breathing & Ungated Dynamic MRI

Pulmonary hypertension (PH) is a chronic disease with high mortality. Several pulmonary
vasodilators that reduce morbidity and mortality, especially with earlier initiation, have been
FDA approved. However, the identification of individuals that would benefit from such therapies
currently requires extensive testing of both the heart and the lungs using multiple modalities,
resulting in high healthcare costs and delay in diagnosis. This proposal seeks to introduce an MR
imaging imaging protocol to diagnose PH within a single imaging session by providing
assessments of both cardiac and pulmonary systems. Current MRI methods have several
limitations in the above setting. This renewal application aims to overcome these drawbacks
using a novel generative SToRM (g-SToRM) framework, which capitalizes on the recent
advances in deep generative models and unsupervised learning. This framework significantly
improves the analysis manifold regularization framework (SToRM) for cardiac MRI, developed
in the previous project. The proposed imaging methods will be validated by comparisons against
current breath-held MRI and CT imaging protocols. The preliminary utility of the quantitative
metrics to predict PH will also be determined.

Public health relevance
The main focus of this research is to develop a novel computational imaging framework for free breathing dynamic MRI. The proposed framework will enable a novel free-breathing protocol for the comprehensive evaluation of the heart and lung. The protocol is expected to enable the early detection and management of pulmonary hypertension is subjects with pulmonary disorders.